Texas A&M University Health Science Center Occupational Safety and Health Training Center

PROJECT SUMMARY
The Occupational Safety and Health Training Program at the Texas A&M University Health Science
Center's School of Public Health (TAMHSC SPH) delivers focused training in occupational safety and health,
with available concentrations in safety, health, and ergonomics for masters level MPH students. Students
completing the program possess knowledge and skills in the general concepts of developing problems and
solutions with cost/benefit analysis related to occupational safety and health/wellness, ergonomics, industrial
hygiene, occupational disease, human anatomy, user-computer interaction, displays and controls, information
processing, industrial process safety, epidemiology, vibration control, and statistics.
The Occupational Safety and Health program at TAMHSC SPH has a long history of producing highly
qualified safety practitioners. The success of the program is demonstrated by the aggressive recruitment of
TAMHSC SPH graduates by industry, healthcare, academia, and governmental agencies. Originally
established in the TAMU College of Engineering through the National Institute for Occupational Safety and
Health (NIOSH) ―Ergonomics Training Grant from 1995-2003, the program and course faculty transferred to
TAMHSC SPH in 2002. The primary strengths of the TAMHSC SPH program are the extensive faculty
expertise and experience in safety and health, medicine, engineering, industrial hygiene, and
ergonomics; the program's critical ties to industry partners, enabling not only capstone field training
opportunities and internships for students but placement of graduates in professional positions with
these industry leaders; and the ability to attract a diverse student body via the school's commitment to
and investment in innovative distributed learning technologies.
TAMHSC SPH has been on the cutting edge of eLearning distributed learning technology since the
school's inception in 1998. Qualified students in the Training Program may pursue their degree through a
combination of on-campus, distance learning, or distributed learning methods. With the NIOSH training grant
funding, this historically successful program will be able to recruit and retain, on a competitive basis, the best
trainee candidates in the country. While the program has been able to recruit and maintain a highly qualified
and successful faculty, including professional engineers, medical doctors, certified professional ergonomists,
and certified industrial hygienists, the NIOSH funding is greatly needed and will assist in recruiting and
retaining new, highly qualified students and faculty members. For this renewal, the program is seeking an
increase of trainees from 2 per year at the masters level to 5 per year (3 masters level and 2 doctoral level) to
support the growth we are seeing in our overall program size and to meet the demand for our students.

Public health relevance
PROJECT NARRATIVE Occupational safety and health specialists are critical to ensuring the safety and health of the nation’s worksites and workforce. The program addresses the shortage of qualified occupational safety and health professionals, due in part to baby boomer retirements in the safety and health field, by delivering a high quality program via a combination of on-campus, off-campus, and distributed learning technologies. We continue to strive to meet the ever-growing Industry demand for our program interns and graduates.